Prenatal Exposure to Anesthesia and Subsequent Neurodevelopmental Disorders

ABSTRACT
Millions of children receive anesthesia each year for surgical and diagnostic procedures, with children also
experiencing prenatal exposures when their mothers undergo surgery during pregnancy. The safety of
anesthetics during brain development has been questioned because preclinical models have shown that
anesthesia exposure during brain maturation disrupts neurodevelopment, and clinical and epidemiological
studies have found that early childhood exposure to anesthesia may be associated with neurocognitive deficits
later in life. There is however still uncertainty about the clinical studies because the data are conflicting, and the
available literature is limited due to residual confounding, selection bias, small sample size, and inadequate
length of follow-up. Prenatal exposures are particularly relevant because this period is characterized by high
fetal sensitivity to neurotoxic agents and correlates to the developmental stage associated with peak brain
vulnerability in preclinical studies of anesthetic neurotoxicity. While the Food and Drug Administration (FDA) has
recently released a warning against the use of anesthetic drugs in pregnant women in the third trimester, this
warning was based on animal studies, with no studies evaluating the effect of fetal anesthetic exposure on brain
development in humans. Studying prenatal exposure is challenging because large numbers of linked maternal-
child records with long durations of follow up in the children are required. In this study, we will evaluate a national
cohort of 2.7 million linked mothers and children who are Medicaid beneficiaries, and identify mothers exposed
to anesthesia for surgical procedures during pregnancy. The Aims of the proposed study are to: (1) Assess the
association between exposure to anesthesia for common surgical procedures during pregnancy in mothers and
neurodevelopmental disorders in their children, (2) Evaluate the impact of exposure during different periods of
gestation, and (3) Determine the increased risk of neurodevelopmental disorders associated with longer
durations of prenatal exposure. A tapered multivariate matching method will be used to match exposed and
unexposed mothers on demographic and medical characteristics, with potential confounders and mediators also
assessed. Cox proportionate hazards modeling, respecting the matched sets, will be used to evaluate the
association between prenatal exposure to anesthesia and neurodevelopmental disorder. Prior observational
studies of anesthesia exposure and neurodevelopmental outcome have been confounded by the presence of
the underlying medical comorbidity in patients who need surgery. Prenatal exposures however offer a unique
opportunity because the exposure to anesthesia stems from the need to address a medical condition in the
mother, and not from any medical comorbidity in the child. As a result, this will allow for the evaluation of children
who received anesthesia without an underlying medical condition requiring surgery. Data generated from this
work will therefore inform the providers and families about the risk of prenatal exposure, but also provide a better
overall understanding of anesthetic neurotoxicity in the developing brain.
!

Public health relevance
PROJECT NARRATIVE Anesthetics have been found to disrupt neurodevelopment during brain maturation in preclinical models, and have also been associated with neurocognitive deficits in clinical and epidemiological studies. The purpose of this project is to assess the safety of prenatal exposure to anesthesia by evaluating long-term neurodevelopmental outcomes in children whose mothers were exposed to surgery and anesthesia during pregnancy. The results of this study will provide important information to clinicians and parents about the risks of prenatal exposure to anesthesia in children. !